Administrative Core

SUMMARY
The Administrative Core of our Translational and Basic Science of Adenomas Center (TBAC) will serve to
optimize and integrate the investigative processes of the Project Labs between each other and the Project Labs
with the Cores. The Administrative Core will provide logistical support, enhance communication, facilitate data
dissemination and create a system for structured oversight of the projects by the PIs. The Administrative Core
will also provide administrative support to facilitate collaborations and communications between the other TBEL
Centers, the Coordinating and Data Management Center (CDMC); NCI staff, collaborating industrial and
academic partners, and collaborating NCI programs (e.g. CISNET, NIST, etc.). The Administrative Core will
provide guidance and enhance communication for and between the TBAC, TBEL Community members and
external partners.
The TBAC is comprised of three teams of investigators in the Project Labs: Project 1 (Grady, Yu, Maroni-
Rana, Dai, Carter), Project 2 (Halberg, Spengler, Snow, Newton), and Project 3 (Dey, Morella, LaChance) and
the Translational Pathology and Data Analysis Core (Matkowskyj, Pickhardt, Sun, Kendziorski, Dinh), who will
function as a seamless unit though the coordination of the Administrative Core. The TBAC will interact closely
with other TBEL Centers and the CDMC in its core mission to elucidate the translational and early biology of
adenomas. The TBAC will also have collaborations with industrial partners and academic partners as needed to
advance the Projects’ studies. The TBAC, other TBEL Centers, TBEL CDMC, industrial partners, and academic
partners will collaborate on the studies in this proposal as well as on any resulting derivative studies that arise
from the TBAC’s highly innovative, productive and significant program of investigation of the basic and
translational biology of adenomas.
The Administrative Core has the following Specific Aims/Goals:
Specific Aim 1: To provide the organizational structure for supporting the key objectives of the TBAC
Specific Aim 2: To provide efficiency in management of large-scale collaborative research efforts involving
multiple institutions and multiple PDs/PIs
Specific Aim 3: To coordinate with the TBEL CDMC and the TBEL community protocol development,
biospecimen sharing, biospecimen blinding, data analysis, data sharing, data harmonization, data deposition,
populating any data commons, and any other relevant functions deemed necessary for TBAC operations as well
as for the larger TBEL community.